Atlanta Network for Training In KUH Scientific Research (ATLANTIS)

PROJECT SUMMARY
This revised application presents our vision for the “Atlanta Network for Training In KUH Scientific Research
(ATLANTIS)”. Our goal is to create a city-wide resource for training the next generation of researchers studying
KUH-related diseases. This program will establish new and strengthen existing collaborative research networks,
research training programs, and career development opportunities that will foster a sustained interest in KUH
diseases, thereby increasing the pipeline of these scientists into the biomedical workforce. The goals of
our program are to: 1) provide the intellectual and research platform to attract and train the next generation of
new basic and clinical scientists into KUH research fields; 2) promote impactful interdisciplinary and multi-
institutional collaborations with the shared objective of KUH-related human disease investigation; 3) promote
KUH biomedical investigator success by enhancing the career development of young scientists; 4) increase
research and teaching collaboration in Atlanta by promoting the interaction amongst Emory University, Georgia
Institute of Technology, Morehouse School of Medicine, and the Atlanta University Center colleges (including
Spelman College, Morehouse College, and Clark Atlanta University); and 5) increase the number of well-qualified
underrepresented minority students entering competitive careers in KUH research. The Administrative Core
will provide the infrastructure to unite scientists from these Atlanta institutions with a shared interest in KUH
research. The Administrative Core will manage educational and research opportunities to support researchers
to generate new knowledge leading to a long-term positive impact on clinical care in KUH-related diseases. The
Administrative Core will be responsible for the overall leadership, coordination, and management of the
ATLANTIS Program, including facilitating interactions among potential trainees and our rich base of preceptors
in KUH research, allocation and oversight of resources, reporting to stakeholders, and promoting the Program.
This will be accomplished by pursuing the following two Specific Aims: Aim 1. Provide oversight and direction,
monitor progress, and promote growth for all components of the ATLANTIS Program. Aim 2. Organize and host
one face-to-face meeting of all Institutional Network Award-supported programs in collaboration with the NIDDK.
The ATLANTIS Program seeks to provide resources to encourage trainees to enter into KUH research, and then
support their career success through the application of novel approaches toward training, professional
development, and networking. The goal of the ATLANTIS Administrative Core is to provide oversight to ensure
that these objectives are met.

Public health relevance
Atlanta Network for Training in KUH Scientific Research (ATLANTIS) is an Institutional Network Award for Promoting Kidney, Urologic, and Hematologic Research Training in Atlanta. Our goal is to create an institutional resource for training the next generation of researchers for the study of kidney, urology, and hematologic (KUH) diseases. ATLANTIS will bring together trainees at multiple career stages who are interested in furthering their scientific research training and pursuing a career in biomedical research.